Kids First Data Resource Center (KFDRC): Harnessing Data-Driven Opportunities in the Present on behalf of the Future of Common Fund Data Ecosystem (CFDE)

Rationale for Multiple PI Proposal
This proposal focuses on activities and collaborations with an initial set of Common Fund DCCs and the
CFDE-CC in response to the Engagement Opportunity “Engaging Common Fund Data Coordinating
Centers to Establish the Common Fund Data Ecosystem (CFDE)” OTA-20-2005. Our proposed
engagements span the 3 key areas defined in the OT EOA and include GTEx, LINCS, HUBMAP, and
SPARC as well as the activities the Kids First DRC is leading as part of the NIH Interoperability Working
Group to further the establishment of the Common Fund Data Ecosystem (CFDE).
The four investigators collaborating on this proposal have distinct professional backgrounds, areas of
expertise, and research tools at their disposal including leading the Kids First DCC/DRP and CAVATICA
efforts.
At the Children’s Hospital of Philadelphia, Dr. Adam Resnick is a cancer and neuroscience research
scientist with expertise in pediatric brain tumors and Dr. Allison Heath is a computer science expert in
large-scale data bioinformatics and compute infrastructure. These experts will work together to lead the
CHOP project team. At Centre Hospitalier Universitaire Sainte-Justine, Dr. Vincent Ferretti develops
bioinformatics software for both large-scale software development and computational genomics. At Seven
Bridges, Dr. Jack DiGiovanna is an expert in cloud-based analysis platforms for bioinformatics that are
scalable, collaborative, and reproducible.
Responsibilities of Investigators
All PIs will share responsibility for ensuring the ethical conduct of the project, upholding the scientific
integrity of the project, administration, oversight and coordination of the project’s management.
Dr. Adam Resnick will serve as the contact PI. He will be responsible for the overall strategy, determining
the prioritization of scientific use cases, and ensuring that the project meets its goals of scientific impact.
Dr. Heath will oversee and facilitate the completion of the technical milestones and deliverables across all
CDFE engagements. Dr. Heath will also be responsible for the execution of interoperability strategies with
CFDE and the NIH IC Stacks. Dr. Ferretti will supervise the KFDRC portal development team and will be
responsible for all of their relevant deliverables, such as authentication with NIH RAS and visualization
integrations with LINCS. Dr. DiGiovanna will supervise the CAVATICA development team and will be
responsible for all of their relevant deliverables, such as GA4GH DRS integration and multi-cloud
capabilities.
Communication and Data Sharing
The PIs will communicate weekly and hold monthly teleconferences with PIs at the other organizations to
discuss the CFDE and all administrative responsibilities. In addition, PIs will meet in person with all
personnel at least annually to assess progress and make major decisions about the direction of the
program. If changes are warranted, PIs will work together to discuss those modifications and the
redistribution of funds, if necessary. A publication policy will be established based on the relative scientific
contributions of the PIs and key personnel. Dr. Resnick will serve as contact PI and be responsible for
submission of progress reports, annual reports to the NIH and all other communication.

Public health relevance
No Text